Optimizing HIV Care in Less Developed Countries

Despite major advances in treatment and prevention of HIV infection, the HIV/AIDS pandemic continues
to cause tremendous morbidity and mortality. Of the 37.7 million people living with HIV worldwide, only
73% are receiving antiretroviral therapy. In 2020 alone, an estimated 680,000 people died from
AIDS-related illness, and nearly two million people are newly infected with HIV each year. The HIV burden
is highest in parts of the world that face the additional challenge of highly constrained resources. HIV
testing and treatment guidelines have continually evolved; however, assessing the benefits associated
with improved testing, more effective antiretroviral therapy, and increasingly effective prevention
interventions is difficult. It is unclear which specific strategies and overall approach would be most
effective for specific populations, given the critical reality of budget constraints.
This competing continuation proposes to expand upon the Cost-Effectiveness of Preventing AIDS
Complications International (CEPAC-I) Model, a computer microsimulation of the natural history,
management, outcomes, costs, and cost-effectiveness of HIV clinical care. This proposal includes
cutting-edge, guideline-informing studies of novel treatments and development of innovative modeling
optimization methods to advance the field. There are two specific aims:
Specific Aim 1: To expand the CEPAC-I microsimulation to address new clinical policy questions focused
on key populations, using data from recent clinical trials and implementation research studies.
Specific Aim 2: To expand upon the optimization model and better determine the combination of HIV care
interventions that most decreases HIV incidence in countries with different epidemic characteristics and
resource constraints.
In close alignment with the 2022 research priorities of the NIH Office of AIDS Research, the goals of this
proposal include reducing HIV incidence, identifying optimal prevention and treatment responses, and
reducing health disparities by improving key population outcomes. The assembled research team has the
ideal combination of skills and experience to address critical questions around the cost-effectiveness of
new interventions for HIV in high-risk populations. The results will lead to new insights to inform clinicians
and policymakers, leading to improved HIV treatment guidelines in multiple resource-limited settings.
RELEVANCE (See instructions):
People living with HIV/AIDS remain untreated and more become newly infected each year. Many testing,
treatment, and prevention methods exist, raising critically important questions about which strategies to
employ when, where, and for whom, given varying epidemic features and resource constraints. We will
expand the CEPAC-I Model to address questions related to the impact of novel treatment and prevention
options and to determine which combinations of interventions will optimize HIV health outcomes globally.